Network Medicine and Systems Pharmacology to Advance Precision Medicine in Combined Pulmonary Hypertension

ABSTRACT
Pulmonary hypertension (PH) due to left heart failure is a common and highly morbid disease characterized by
molecular, histophenotypic, and clinical heterogeneity that hampers progress in diagnosis and therapeutic target
discovery. Biochemical markers and treatments for left heart failure-PH patients are lacking. Some patients with
left heart disease develop combined pre- and post-capillary PH (CPH), characterized by severely elevated
pulmonary vascular resistance, vascular remodeling, and early death. This vascular profile cannot be ascribed
to pulmonary venous hypertension (PVH) alone. For example, we show that compared to PVH, patients with
CPH are younger but have a similar duration and severity of left heart disease. We also reported that the genetic
profile of CPH is divergent from patients with PVH but is also highly diverse among CPH patients. This
observation is consistent with the complex patterns of vascular remodeling observed at autopsy in CPH, and,
collectively, suggest that opportunity may exist to leverage the unique pathobiological profile of individual CPH
patients for optimizing diagnosis and treatment.
We present preliminary data innovating network medicine to exploit unique pathobiological features in
patients with a complex left heart disease associated with PH. We developed patient-specific networks focusing
on functional/physical protein-protein interactions (PPIs), generating a unique molecular ‘wiring map’ for each
patient. Network topology predicted pulmonary hemodynamics and tissue histologic features (e.g. fibrosis) in
individual patients despite phenotypic heterogeneity across the cohort. Therefore, we propose to use this
approach to advance precision medicine in CPH, which sets the framework for our central hypothesis: In CPH,
shared features across patient-specific PPI networks will identify next-generation biomarker(s) that are based
on functional molecular pathways, disease-specific, and prognostic. We postulate also that targeting PPIs unique
to individual patients using systems pharmacology will provide a novel avenue to individualize drug therapy.
In Aim 1 we will profile the CPH, PVH, and pulmonary arterial hypertension (PAH) transcriptome (N=
50/group) to identify PPIs that are shared by all CPH patients, but distinct from PVH/PAH. We will use
endophenotype enrichment, network topology, genetic context, and protein expression data as filters to identify
next-generation CPH biomarker candidates in silico. Finally, we will validate the CPH biomarkers for associations
with functional capacity and prognosis in two external cohorts and human lung samples. In Aim 2 we will integrate
drug-protein interaction and PPI network data to identify patient-specific repurposed therapies and use functional
genetics, drug effect-protein expression data, and drug availability and safety profiles to filter therapeutic
candidates. Finally, we will perform five N-of-1 placebo-controlled cross-over trials using mechanistic endpoints
to test the validity of our systems pharmacology pipeline for individualized drug selection. These innovative
experiments advance precision medicine in CPH, a highly morbid disease that lacks treatment.

Public health relevance
NARRATIVE Pulmonary vascular disease is common and associated with high mortality in patients with heart failure, but the underlying pathobiology is poorly understood. We propose novel methods to identify proteins that contribute to functional status and prognosis in patients with heart failure and pulmonary vascular disease. We also propose new methods to identify and test, in patient-specific trials, repurposed treatments for this condition.